Protective Mechanisms in Pancreatic Beta-cells

Project Summary/Abstract
Pancreatic -cells are responsible for synthesis and secretion of insulin in response to a glucose challenge.
They are essential for survival of the organism as the only cell type capable of expressing and secreting insulin.
Since they are essential, yet they have a limited capacity to replicate, it would be evolutionarily advantageous
for -cells to possess mechanisms to protect themselves from a variety of cellular stresses. The formation of
reactive oxygen and nitrogen species (ROS and RNS), such as hydrogen peroxide and nitric oxide, have been
implicated in the demise of -cells during diabetes development. Indeed, nitric oxide, produced in -cells in
response to proinflammatory cytokines (IL-1β and IFN-γ), inhibits mitochondrial oxidative phosphorylation and
insulin secretion, hydrogen peroxide causes oxidation of proteins, lipids, and DNA, and both cause DNA damage
that can lead to cell death if the damage is not repaired. Furthermore, it has been suggested that -cells are
vulnerable to damage due to reportedly low levels of antioxidants; however, this view is at odds with several
fundamental characteristics of -cells. ROS are produced by the pathway responsible for glucose sensing and
glucose-stimulated insulin secretion (mitochondrial oxidative metabolism), and their production is directly
proportional to the blood glucose concentration. Additionally, this pathway is sensitive to inhibition by nitric oxide.
Our central hypothesis is that, because they are essential for organism survival, β-cells are evolutionarily
programmed to be protected from damage, and our long-term goal is to identify the mechanisms by which this
protection occurs. There are two aims: (1) to test the hypothesis that the thioredoxin/peroxiredoxin antioxidant
system promotes β-cell survival and function, and (2) to test the hypothesis that IL-1 signaling promotes
protective responses in islet endocrine cells. Using biochemical, molecular, immunological, genetic, and omics
approaches, these studies will initiate investigations into the mechanisms by which pancreatic β-cells protect
themselves against oxidant, free radical, and environmental challenges. Proposed experiments will begin during
the K99 phase, with expertise and technical assistance provided by the mentor and advisory team at MCW, and
will be completed upon transition to the independent R00 phase. We believe that the pathways of protection that
are identified in these studies will provide novel targets for therapeutic intervention designed to preserve
functional β-cell mass and attenuate or prevent diabetes development.

Public health relevance
Project Narrative The formation of reactive oxygen and nitrogen species (ROS and RNS), such as hydrogen peroxide and nitric oxide, have been implicated in the demise of β-cells during diabetes development. However, we have demonstrated (1) that β-cells maintain a robust antioxidant defense system that allows them to detoxify ROS and RNS, and (2) that interleukin-1β and nitric oxide may play a protective role in β-cells. The broad goals of these studies are to identify mechanisms of β-cell protection from environmental challenges so we can better understand how β-cells fail during the pathogenesis of diabetes.